Short-term estradiol use in middle-age: implications for female cognitive aging

DESCRIPTION (provided by applicant): Estrogen administration begun during a critical window near menopause is hypothesized to prevent or delay age-associated cognitive decline. However, due to potential health risks women often limit use of estrogen therapy to a few years to treat menopausal symptoms. The long-term consequences for the brain of short-term use of estrogens are unknown. The long-term goal of the research is to determine the consequences for the female brain and for female cognitive aging of short-term exposure to estrogens during middle-age such as that used by women during the menopausal transition. The central hypothesis to be tested is that lasting changes in levels of estrogen receptor alpha (ERα) and in the insulin-like growth factor-1 (IGF-1) system in the hippocampus resulting from short-term exposure to exogenously administered estradiol in middle-age following the cessation of ovarian function permanently alters the interaction between ERα and the IGF-1 system in the hippocampus of the aging female brain resulting in increases in levels of ERα target genes and proteins and in enhancement of hippocampus-dependent memory. Guided by preliminary data, this hypothesis will be tested by three specific aims: 1) Determine the nature of the interaction between IGF-1 and ERα in hippocampal neurons; 2) Determine the respective contributions of ERα and IGF-1 receptors in the ability of short-term estradiol exposure to exert lasting impacts on the hippocampus and on hippocampus-dependent memory; and 3) Determine the extent to which the effects of IGF-1 on the hippocampus and on hippocampus-dependent memory in aged females vary dependent upon previous hormone experience. Experiments under the first aim will use primary hippocampal cell cultures to determine the ability of IGF-1 and its signaling pathways to induce ERα-mediated transcriptional activity from an estrogen response element driven reporter gene and to induce activation on of specific phosphorylation sites on ERα. Experiments under the second aim will assess the impact of pharmacological blockage of brain IGF-1 receptors, ERα, or both on the ability of short-term estradiol exposure in middle-aged ovariectomized rats to exert lasting impacts on ERα target genes and associated proteins in the hippocampus and on hippocampus-dependent memory. Experiments under the third aim will determine effects of centrally administered IGF-1 on hippocampus-dependent memory, IGF-1 associated signal transduction pathways, and ERα target genes and associated proteins in aged ovariectomized rats that have and have not undergone estradiol exposure during middle-age. This research is expected to have a positive impact on the study of female cognitive aging by providing elucidation of mechanisms by which a relatively short-term exposure to exogenously administered estradiol during a critical period following the cessation of ovarian function exerts lasting impacts on the hippocampus and on cognition. PUBLIC HEALTH RELEVANCE: As the population of the United States ages, increased incidence of age-associated dementias will become a major public health issue. Interventions that could delay the onset of cognitive decline by even one or two years would have a major public health impact. These data will help determine the mechanism by which short- term administration of estrogens near the time of menopause could exert lasting benefits to the cognitive health of women as they age.

Public health relevance
As the population of the United States ages, increased incidence of age-associated dementias will become a major public health issue. Interventions that could delay the onset of cognitive decline by even one or two years would have a major public health impact. These data will help determine the mechanism by which short- term administration of estrogens near the time of menopause could exert lasting benefits to the cognitive health of women as they age.